Early Phase Pain Investigation Clinical Network Hub at the University of Washington

PROJECT SUMMARY
The concurrent public health crises of opioid misuse with associated overdose death epidemic and inadequate
options for pain management require innovative, far-reaching, safe and effective solutions. The University of
Washington’s (UW) Division of Pain Medicine (UW Pain) is a Specialized Clinical Center within EPPIC-Net,
representing the Pacific Northwest region and beyond. UW Pain (“hub”) includes four core clinical sites: UW
Medical Center, Harborview Medical Center, Seattle Children’s Hospital, and Seattle Cancer Care Alliance. The
hub is driven by an experienced core team that has leveraged existing infrastructure and resources and
identified a flexible, diverse, and robust network of spoke sites to help meet the broad needs of EPPIC-Net.
Our team of principal investigators has extensive relevant experience in conducting multi-site clinical trials
across all phases and in deep phenotyping, such as behavioral and psychological profiling, quantitative
sensory testing, neuroimaging, and biomarker research. The team is further supported by research
coordinators and will work closely with UW’s Institute for Translational Health Sciences (ITHS), the site of UW’s
Clinical and Translational Science Award. Relevant UW departments affords access to disease-specific
expertise and patient populations. Our network spans multiple states and specialties, allowing access to
geographically and demographically diverse (including underrepresented and underserved) patient populations
and a broad range of medical and surgical disorders for which pain is a clinically significant component. To
achieve the goals of the HEAL initiative’s EPPIC-Net, we have: (1) Established UW EPPIC-Net Hub and
Spokes infrastructure, provide scientific leadership and administrative oversight, and apply our expertise in
design and conduct of high-quality multidisciplinary Phase 2 clinical trials and biomarker validation studies; (2)
Developed policies and procedures for rapid design, initiation, recruitment, conduct, and closure of high quality
multidisciplinary Phase 2 clinical trials and biomarker validation studies for specific pain conditions at UW Pain
EPPIC-Net Hub and Spokes, and; (3) Established mechanisms for communication, education and training, and
performance assessment of the UW-EPPIC-Net Hub and Spokes, to assure efficient and timely utilization of
resources to most effectively recruit participants.

Public health relevance
PROJECT NARRATIVE The University of Washington’s (UW) Division of Pain Medicine (UW Pain) is one of the HEAL Initiative’s Early Phase Pain Investigation Clinical Network Specialized Clinical Center. Its breadth and depth of pain expertise, functional infrastructure, accessible resources, and established affiliated networks and inter-state collaborations provide access to geographically and demographically diverse patient populations. The UW EPPIC-Net Hub infrastructure provides scientific leadership and administrative oversight of high-quality multidisciplinary Phase 2 clinical trials and biomarker validation studies.